Specification and patterning of the Drosophila retina by the Pax6 transcription factor

Project Summary: A critical step during development is organogenesis, the process by which primordial
tissues give rise to complex three-dimensional organs. The question of how individual organs acquire their
unique identity is of fundamental importance to understanding both normal development and congenital
disease. The over-arching goal of this project is to understand how the earliest steps in the process of eye
formation are controlled. Our efforts will focus specifically on the role that the Pax6 transcription factors,
Eyeless (Ey) and Twin of Eyeless (Toy), play in specifying and patterning the Drosophila compound eye. The
fly retina is an excellent model system for studying organ formation because the steps of its cellular
development are well defined, a robust collection of genetic tools allow for the manipulation of relevant genes,
a wealth of markers allow for identifying deviations in developmental trajectories, and the tissue is amenable to
genomic methods which illuminate the transcriptome, transcription factor binding, chromatin accessibility, and
histone modifications. While an abundance of reagents and tools has been applied to the study of other genes
involved in eye formation, understanding the roles that Ey and Toy has been hampered by a scarcity of
molecular and genetic reagents associated with these genes. Another obstacle has been the near complete
lack of attention placed on studying the role that Toy plays in the eye. As such, we have an incomplete view of
Pax6 function which is skewed heavily towards Ey. We have overcome these limitations by creating new
methods as well as new molecular and genetic reagents that will allow us to determine the individual and
combined contributions that Ey and Toy make to eye formation and patterning. Our studies will, therefore, fill an
enormous gap in our knowledge about these important transcription factors. 1Our studies will also impact
human health as mutations in human Pax6 are the most common single cause of Aniridia, a congenital eye
disorder that occurs 1 in 50,000 live births. Patients with this disorder suffer from reductions in visual acuity,
increased sensitivity to light, and progressive loss in vision.

Public health relevance
Project Narrative: The proposed project is aimed at understanding how the Pax6 transcription factor specifies the fate of the eye. The discoveries resulting from our investigations will fill several gaps in our knowledge of normal eye development. Our studies will also impact public health as mutations in human Pax6 are the underlying cause of the congenital retinal disease Aniridia.